CSHL Neuroscience of Addiction Course (2024-2027)

Cold Spring Harbor Laboratory Lecture Course
NEUROSCIENCE OF ADDICTION (2024-2027)
Abstract
Drug addiction is among the most prevalent and costly neuropsychiatric disorders faced by our nation. Acute
and repeated exposure to drugs produces neuroadaptation and long-term memories of the experience, but the
circuitry, cellular and molecular adaptations underlying it are only partially understood. There is a need for
increased research in this area that bridges basic and clinical perspectives. The primary objective of the
proposed lecture-and-discussion course is to provide an intensive discussion of the fundamentals, state-of-the-
art advances and major gaps in the neurobiology of drug addiction. Targeted to both new and experienced
investigators, the course will combine formal presentations and informal discussions to convey the merits and
excitement of behavioral, circuitry, cellular and molecular approaches to drug addiction research both at the
preclinical and clinical levels. A range of disciplines and topics will be represented, including noninvasive brain
imaging to identify drug targets and adaptive processes; neuroadaptive processes at the molecular and cellular
level, neural circuits/networks and their modulation, the relevance of genotype and genotype/environmental
interactions to susceptibility and drug response; tolerance and adaptation at the cellular level and approaches
to exploiting the daunting volume generated by neuroinformatics. The course will provide an integrated view of
current and novel research on neuroadaptive responses to addictive drugs. The course will foster discussion
on career development, ethical considerations, collaboration, and integration, as well as provide critical
information needed to construct models of addiction as a disease and identify novel targets for treatments.
Beyond the plane of scientific endeavor, the information is vital for formulating public policy and for
enlightening the public on the neurobiological consequences of drug use and addiction. The course is
designed to generate awareness and interest in multiple levels of analysis, open conduits for collaborations
and present novel routes to investigating the neurobiology of addictive drugs. The course makes every effort to
include a diverse group of participants, being particularly mindful of the inclusion of women, US minorities and
a good balance of national and international scientists. The course has an excellent track record of training and
retaining young scientists in neurobiological and specifically in addiction research. Finally, CSHL has
developed mechanisms for dissemination of the scientific presentations to a broader audience through the use
of open access video archives of the lectures available on Youtube and similar sites.

Public health relevance
Cold Spring Harbor Laboratory Lecture Course NEUROSCIENCE OF ADDICTION (2024-2027) Narrative The societal consequences of drug abuse and drug addiction are enormous. Over the past forty years, research on the mechanisms of action of addictive drugs have focused on pharmacology and behavioral pharmacology studies. With the rapid growth in molecular and systems neuroscience in the last two decades and the completion of the human genome more than a decade ago, integration between behavioral or physiological responses and molecular, genetic and cellular responses to addictive drugs is increasingly possible, opening new avenues for the understanding of drug use and drug abuse. Together with the development of increasingly sophisticated preclinical models of the disorder in rodents, amalgamation of these disciplines into contemporary research into the biobehavioral basis of the vulnerability to develop drug addiction requires a profound appreciation for the strengths and weaknesses of each approach. The theme of the proposed lecture course is to provide young and emerging scientists with the most up-to-date and exhaustive information on how tissues, cells and genes respond to drugs of abuse differently between individuals across species. This week-long residential course is targeted to both new and experienced investigators, and combines formal presentations and informal discussions to convey the merits and excitement of behavioral, cellular and molecular approaches to drug addiction research. The course will stress the significance of this approach not only to the most costly neuropsychiatric disorder, addiction, but its applicability to learning, memory, and other disciplines of neuroscience. Research on the psychological, neural, cellular and molecular and cellular changes that occur in response to drugs is critical for clarifying whether adaptive processes are diverse for each stage of addiction and for each drug of abuse. Ultimately, new treatments for these disorders are likely to emerge from a better understanding of the processes that go awry in vulnerable individuals during the transition from controlled to compulsive drug seeking and taking.